Microbiota-mediated fibrotic remodeling in the inflamed intestine

ABSTRACT
Fibrotic disorders are associated with an estimated 45% of human deaths. Chronic inflammation-associated
intestinal fibrosis is a significant complication in ~40% of Crohn’s disease (CD) patients. This condition causes
severe intestinal thickening and blockage, and is the most common reason for bowel resection in CD patients.
Despite this public health problem, there is minimal understanding behind the disease process of CD-
associated fibrogenesis. The microbiota provides a putative causal link to CD and other inflammatory bowel
diseases, but it remains unknown which specific microbial products induce distinct cellular responses and host
phenotypes. We hypothesize that a class of secreted microbial small molecules from a dysbiotic microbiota
disrupts local host metal homeostasis and promotes inflammation-associated fibrosis by altering macrophage
function. Nutrient metals are essential for living organisms, and the intestine is a battleground where host and
resident microbes fight to acquire metal. Host metal scavenging and sequestration defends against infectious
diseases, but its contribution to chronic inflammation-associated disease is not well understood. Here we
reveal a novel inflammation-associated fibrosis model using gnotobiotic Il10-/- mice mono-colonized with
adherent-invasive Escherichia coli (AIEC) NC101. Fibrosis requires bacterial production of a specific small
molecule metallophore that is over-represented in AIEC strains and abundant in the metagenomes of CD
patients. Surprisingly, fibrosis does not require bacterial uptake and utilization of the metallophore, suggesting
it targets the host. Indeed, this metallophore induces metal-starvation genes in macrophages. Metallophores
are abundant in the gut microbiota, with hundreds predicted in the metagenomes of the Human Microbiome
Project (HMP). Therefore, our project has broad implications and supports a model in which excessive metal
chelation may characterize a dysbiotic microbiota that favors fibrotic vs. non-fibrotic CD. Iron and zinc
deficiency are associated with CD and promote fibrosis in animal models of extra-intestinal fibrosis.
Accordingly, the objective of this project is to define mechanisms by which microbial metallophores promote
fibrogenesis, and link microbial metal scavenging and altered host metal homeostasis with CD-associated
fibrosis. We have generated numerous AIEC strains that abolish the synthesis and/or transport of
metallophores. We will utilize these strains and purified metallophores in our novel inflammation-associated
fibrosis mouse model, an essential tool that recapitulates the histologic and molecular features of CD-
associated fibrosis. We will define the metal specificity underlying the pro-fibrotic in vivo effects using NC101
and clinical strains. We will also identify the pro-fibrotic colonic monocyte/macrophage population and explore
mechanisms by which altered metal availability promotes this macrophage phenotype. Understanding
precisely how specific bacterial products impact distinct host disease phenotypes is essential for developing
microbiota-based diagnostics and therapeutics for inflammatory bowel diseases.

Public health relevance
PROJECT NARRATIVE Chronic intestinal scarring and thickening, termed intestinal fibrosis, afflicts up to 40% of Crohn’s disease (CD) patients, yet there is no known cure and few treatment options. The fundamental processes underlying CD-associated fibrosis are unknown, partly due to the lack of relevant animal models that recapitulate this complex disease process. Our lab has developed a novel CD inflammation-associated fibrosis model driven by a metal-binding small molecule of the gut microbiota. The objective of this project is to define the mechanisms by which this metal-binding molecule promotes fibrosis and link microbial metal scavenging with fibrogenic disease.